Community Engagement

PROJECT SUMMARY
Community Engagement
Our Center represents an important resource of instrumentation, software, methods, and expertise that we have
developed and optimized. The ultimate and overarching goal of the NCDIR is to enable the widest range of
researchers in the biomedical community to access our interactomics pipeline resource, and to transfer the
pipeline technology to researchers’ laboratories. To achieve this goal, we will both create a body of researchers
from a wide diversity of fields who are trained in the use of NCDIR technology – they will act as nuclei to seed
further spreading of our approaches in the community - and use a variety of methods to advertise and
disseminate our approaches throughout the community. Thus, we will continue to seek new collaboration and
service projects (C&SPs). Each C&SP presents specific technological roadblocks, in key areas of research,
which can be already addressed by out Center’s pipeline. These serve to beta-test our technology, ensuring it is
bench-ready for any researcher and generally applicable. The C&SPs also form a crucial initial step in our
Community Engagement, through working with a broad spread of biomedical researchers to make existing and
newly-developed TR&D technologies readily accessible and generally available. Through C&SPs and other
collaboration and training opportunities, we will provide direct training for researchers at all academic career
stages and from scientifically diverse backgrounds, specialists and non-specialists, in the use and application of
NCDIR technologies for their own research programs. To ensure that we maximally reach the research
community, we have strategies to actively engage these scientists with a goal of building their technical
competence. In addition, we dedicate considerable resources to provide training to the greater community
through non-direct contact such as our website. We will also facilitate the research of other scientists by actively
distributing NCDIR research, technology, computational tools, methods, education, and training to the greater
biomedical community, utilizing both traditional and new media approaches for dissemination.